Chemistry-Biology Interfaces at UCSD

PROJECT SUMMARY
A predoctoral training program in Chemistry-Biology Interfaces (CBI) at University of California, San Diego (UC
San Diego) will leverage our historical strengths in interdisciplinary research and join diverse faculty for a
robust training environment. UC San Diego has historically excelled at the interface of chemistry and biology,
and the renewed support from the University has ensured a strong and vibrant program in the future. Many of
the training faculty in this program are new to the University (within the past 10 years), and the collaborative
bonds established in this proposal represent the best of interdisciplinary training. The proposal aims to train 10
students each year, with 20% of these slots supported by a match from the Graduate Dean, starting in their
second year of graduate studies, and offering support for two years. The proposal establishes a special
curriculum for students who will participate in research within preceptor laboratories in Department of
Chemistry and Biochemistry, Skaggs School of Pharmacy and Pharmaceutical Sciences, or Pharmacology.
The respective Deans/Directors from each of these divisions/centers have offered significant institutional
support, including the topping off of tuition/fees and stipends, providing additional trainee slots in the form of
fellowships, and assisting administrative and organizational costs associated with this program. The curriculum
we have put together offers a training and personal/professional growth experience that will be unique to this
program. This includes required coursework in Chemical Biology and Scientific Ethics (with a Scientific Ethics
refresher workshop); a CBI Seminar Series that invite world-class scientists; a CBI Workshop that focuses on
research, personal, and professional growth; an annual Career Day; an annual Industrial Tour; an annual CBI
Symposium of research accomplishments; and regular interaction/feedback from the world-class faculty in our
CBI faculty. Given our strengths for interdisciplinary and collaborative research and the outstanding pool of
qualified trainees, we believe that CBI at UC San Diego offers an excellent and unique training opportunity.

Public health relevance
PROJECT NARRATIVE This training program in Chemistry-Biology Interface at UC San Diego is designed expressly for the training of graduate students, the nation’s future scientific leaders, in the practice of chemical biology. The students will be instructed and mentored in this vibrant interdisciplinary field that contributes to the fundamental knowledge about living systems and applies that knowledge to enhance health, lengthen life, and reduce illness and disability. The student training benefits from direct mentorship of a select faculty group, including research theory, methods, practice, ethics, and camaraderie.